Defining Long Term Neurological Consequences Following Asymptomatic ZIKV Infection

Project Summary
Recent work has underscored the potential for chronic neurological consequences following systemic viral
infections. Although mild and asymptomatic cases make up the vast majority of human viral infections, studies
in this area to date have overwhelmingly focused on models of severe viral infection and encephalitis. Zika
virus is an emerging flavivirus of global concern that is most known for its connection with congenital sequalae
following infection in utero. However, despite possessing tropism for neurons, astrocytes, and neural
progenitors, infection in healthy adults is asymptomatic in approximately 80% of cases. We have developed an
immunocompetent mouse model of systemic ZIKV infection in which infected animals do not display any
clinical illness or differences in weight gain, despite ZIKV being detectable in the brain. In this asymptomatic
model, we demonstrate leukocyte recruitment into the brain and the establishment of brain tissue resident
memory cells (TRMs) up to 32 weeks post infection. Transcriptomic and metabolomic approaches demonstrate
dysfunction in pathways related to inflammation, neurodegeneration, and senescence in the postinfectious brain,
while computationally driven behavioral approaches illustrate perturbed movement patterns in freely moving
mice at 32 weeks post infection. Based on their deleterious role in other neurotropic infections, we propose that
CD8 T cell residence in the brain contributes to the induction and maintenance of these deficits. We thus
hypothesize that depletion of CD8 T cells during acute infection will prevent these phenotypes. Results from
this proposal will define the neurologic consequences of asymptomatic ZIKV infection while describing roles
for CD8 T cells in promoting neurologic sequelae in the postinfectious brain.

Public health relevance
Project Narrative Neurotropic viral infections are linked to long term neurological consequences and neurodegenerative disease. However, most studies of this connection to date have used models of severe infection, despite mild and asymptomatic cases representing the overwhelming majority of human cases. We propose using a new model of asymptomatic Zika virus infection to identify long term neurological consequences that occur weeks to months following recovery. Cytotoxic T lymphocytes will be studied as a potential agent of neurological sequelae following asymptomatic infection.